Inter-regional study of transmission, adaptation and pathogenesis of viruses with pandemic potential in Southeast Asia and West/Central Africa

PROJECT SUMMARY
Background: In Cambodia, ticks and tick-borne diseases are neglected and data are still lacking. Objectives:
In the present proposal, we aim to identify tick species and associated pathogens including virus and bacteria
circulating in rural Cambodia. Additionally, we plan to investigate transmission risk of a number of selected tick-
borne pathogens known to circulate in the region in human by assessing seroprevalence (IgG) and tick bite
biomarkers in people living in the communities where ticks are captured. Methods: Our study will be nestled in
a study, namely “Study of dengue-like illness in Kampong Thom Province, Cambodia” (DENTHOM) which is part
of a NIH/NIAID-funded project, namely “Inter-regional study of transmission, adaptation and pathogenesis of
viruses with pandemic potential in Southeast Asia and West/Central Africa” (U01 AI151758-01). Tick collections
will be planned according to the parent study (DENTHOM). In terms of human samples, the present study
involves only biospecimen collected in the framework of the DENTHOM study. No collection of human biological
specimens will be specifically performed for the present proposal. The collected tick specimens will be first
identified morphologically and confirmed using Maldi-TOF MS. Once identified, the specimen will be killed and
kept at -80°C. Ticks samples will be tested for known viruses and bacteria using molecular assays and for novel
pathogens using metagenomics sequencing. Human samples will be used for seroprevalence study of commonly
known tick-borne viruses and bacteria circulating in Asia and for tick bite biomarkers. Expected outcomes: Our
study will provide current state of knowledge of ticks and potential risks of tick-associated pathogens circulating
in Cambodia. The findings of our study would be useful for assessment of host/vector interaction and instruct
diagnosis of tick-borne pathogens.

Public health relevance
PROJECT NARRATIVE The present study will focus on tick diversity and their endofauna to bring light on tick-borne diseases and their transmission in rural Cambodia. It will be nestled within a NIH-funded project “Inter-regional study of transmission, adaptation and pathogenesis of viruses with pandemic potential in Southeast Asia and West/Central Africa,” also known as the “PICREID” project (U01 AI51758-01). Our findings will provide relevant data which will be useful for diagnosis and appropriate treatment of tick-borne pathogens, and assessment of host/vector interaction by enabling documentation of previous exposure to ticks and tick-borne pathogens.